PRMS - Protocol Review and Monitoring System

Protocol Review and Monitoring System/Institutional Scientific Review Committee The Protocol Review and Monitoring System/Institutional Scientific Review Committee (PRMS/ISPRC) was constituted in 1993 to provide rigorous internal scientific review for all clinical oncology protocols conducted by JCCC investigators. Per NCI mandate, the committee conducts full scientific review of all interventional cancer clinical research protocols. Drs. Robert Elashoff and John Glaspy serve as the Chairman and Vice- Chairman, respectively, of the PRMS/ISPRC. Under their direction, the committee reviews the required elements of the protocol, and other factors such as adequate research staffing, any competing trials, appropriately formulated data collection forms, and utilization of Cancer Center resources.